Developing new biophysical models of choroid fissure closure in zebrafish and foveal pit formation across species

PROJECT SUMMARY
The proposed project is a physics and biology collaboration at the University of Northern Colorado (UNC) to
model morphogenesis processes in the developing vertebrate eye. We will create new, quantitative, biophysical
models of choroid fissure closure and of foveal pit formation, test these models against experimental data from
zebrafish and other organisms, and iterate to refine the models and maximize their predictive power. The project
design is cutting-edge, yet accessible to undergraduate (UG) participation. UNC physics and biology majors will
be recruited and engaged in all aspects of research, including experiment design and execution, computer
simulations, presentation of results at conferences, and preparation of manuscripts for submission to journals.
The overall project goals are to: 1) address a basic research need for quantitative models of eye morphogenesis,
incorporating key new data and unifying principles of central nervous system morphogenesis, 2) illuminate
relationships between molecular regulation and mechanical forces giving rise to shape changes in the eye, and
3) study mechanisms of developmental eye disorders, such as coloboma (failure of choroid fissure closure) and
foveal hypoplasia (underdevelopment of the foveal pit). These goals align with NIH’s mission “to seek
fundamental knowledge about the nature and behavior of living systems” and with NEI’s strategic plan. They
also target AREA priorities to provide UG research experiences and enhance the PUI’s research environment.
We will achieve these goals by executing three independent Specific Aims. Aim 1 is to iteratively develop and
validate a novel bilayer vertex model of choroid fissure closure in zebrafish. In Aim 1a we will code the wildtype
model into simulation software that can be run by undergraduates on a supercomputing cluster. In Aim 1b
undergraduates will carry out experiments with zebrafish embryos, genetically and/or chemically manipulating
cadherins, actin, and “pioneer cells”. Each manipulation will correspond to a parameter in the bilayer vertex
model, enabling validation and refinement of the model at each experimental step. Aim 2 is to extend a “tension-
based morphogenesis” model of cerebellar foliation to the developing retina, with its similar cell types, but
different geometry and growth profile. We will determine if these model inputs lead to foveal shape outputs that
resemble concaviclivate foveas seen in nature (preliminary results suggest they do). The model analysis will be
incorporated as a project in the PUI’s existing required course, Computer Applications in Physics, as part of the
mathematical training for UG physics majors working on this Aim. Finally, Aim 3 builds on preliminary work,
already involving four UGs, that investigates elastic creasing instability as a potential mechanism of foveal pit
formation. Creases on compressed surfaces of elastomers bear a remarkable resemblance to convexiclivate
foveal pits such as those in Anolis lizards. We will specifically investigate creases formed in spherical shells that
mimic the retinal geometry, and validate our experimental results with finite element simulations using the neo-
Hookean hyperelastic model in COMSOL.

Public health relevance
PROJECT NARRATIVE Our physics and biology collaboration will develop new mathematical and gel-based models of eye morphogenesis, and test the models' predictions against experimental data from zebrafish and other organisms. This work will address a basic research need for quantitative eye morphogenesis models, shed light on the biophysical mechanisms of choroid fissure closure and foveal pit formation, and lay groundwork for future studies aimed at treatment and prevention of colobomas, foveal hypoplasia, and other developmental diseases of the eye. Undergraduate physics and biology majors at the University of Northern Colorado will be involved in all aspects of the proposed research.